FIND-seq: A Novel Cell Sorting Technology to Enable Investigation of Rare Cells in Primary Human Tissues

ABSTRACT
Rare cells, such as pathogenic astrocytes, play an important role in tissue physiology and pathology, including
neurodegenerative and CNS disorders. However, the investigation of these cells is often hindered by the lack of
known surface markers to isolate them, which is necessary for in-depth profiling. FIND-seq, a novel cell sorting
technology developed by Dr. Adam Abate, a founder of Fluid Discovery, which enables rare cells or nuclei to be
isolated based on DNA or RNA markers with single molecule sensitivity, even in cases where no known surface
markers are available. Fluid Discovery, is focused on commercializing FIND-seq for neurodegenerative disease
research and broader single-cell genomics markets. This Fast-Track SBIR will support the translation of the
technology from the lab to the company, its development into a first-generation commercial product, and its
validation on an important neurodegenerative disease use-case. The successful completion of these aims is
crucial for the commercialization of FIND-seq and for Fluid Discovery's ability to meet the growing demand for
more effective and efficient rare cell sorting and sequencing technologies.

Public health relevance
NARRATIVE Fluid Discovery is developing FIND-seq, a novel cell sorting technology that allows for rare cells or nuclei to be isolated based on DNA and RNA markers. The technology is broadly applicable to any tissue type from which whole cells or nuclei can be recovered, facilitating the investigation of rare cell subsets directly from primary human tissue. FIND-seq is uniquely positioned to meet the growing demand for more effective and efficient rare cell sequencing technologies.